Exploratory investigation of bilingualism, executive function, and brain organization in children with autism

Project Summary
Autism spectrum disorder (ASD) is associated with marked heterogeneity with respect to the development of
executive function (EF) abilities. In the United States, 12 million children primarily speak a language other than
English in the home, suggesting that 1 in 4 children with ASD are being raised in a bilingual environment.
Individuals who speak two languages fluently sometimes perform better on tasks of EF than monolingual
individuals. Despite the potential advantages that bilingualism may confer, clinical practitioners commonly
advise against providing a bilingual environment for children with developmental disabilities. The rationale for
this recommendation is that concentrating on one language should better support a child’s language
development. Yet, a growing body of work suggests there are no negative effects of being raised in a bilingual
environment for children with neurodevelopmental disorders. Preliminary evidence even suggests possible
associations between bilingualism and enhanced EF in some children with ASD. Still, there is little research
specific to bilingualism in children with ASD, leaving clinicians struggling to develop informed
recommendations for families of children with the disorder. Currently, there is no research characterizing the
relationship between bilingualism, EF abilities, and brain network organization in children with ASD. This
project will investigate these links for the first time. This exploratory project will examine the neural basis of EF
in 50 monolingual and 50 bilingual children with ASD between the ages of 8-12 years with two aims: 1) to
characterize associations between bilingualism and EF abilities in children with ASD using an informant-report
indicator of EF and performance-based laboratory tasks, and 2) to characterize associations between
bilingualism and brain functional organization underlying EF abilities in children with ASD using both task-
based fMRI and resting-state functional connectivity dynamics. The project will be conducted in Los Angeles,
where nearly 60% of the population is bilingual. This research addresses the strategic plan from the
Interagency Autism Coordinating Committee that aspires to understand alterations in brain function in ASD to
better enable the development of targeted interventions and societal accommodations that improve quality of
life for individuals on the spectrum.

Public health relevance
Project Narrative Autism spectrum disorder (ASD) affects 1:44 children, making it an urgent public health concern. The ability to speak two languages fluently may be associated with advantages outside of the language domain, including enhanced cognitive abilities. Understanding the cognitive and neural consequences of bilingualism in children with ASD is critical for informing clinician recommendations regarding how many languages to speak in the home.